Bioinformatics Shared Resource

PROJECT SUMMARY: BIOINFORMATICS SHARED RESOURCE
Bioinformatics has become an essential part of cancer research due to the high-throughput nature of multi-
omics data (such as genetic, genomic, epigenetic, transcriptomic, proteomic and metabolomic) that are being
generated from cancer research projects. Thus, a tremendous need exists for developing computational
infrastructure for the collection, processing, storage, analysis, and facilitation of the use of such data by the
cancer research community. The main goals of the Bioinformatics and Systems Biology (BSB) Shared
Resource are to facilitate access to bioinformatics resources that include hardware, software and personnel
expertise; train researchers in the use of such resources; and provide custom support for research projects
including the development of cutting-edge tools and protocols to match the rapidly changing technologies in
the realm of cancer research. BSB Shared Resource is equipped with locally installed bioinformatics tools and
databases related to cancer research backed by state-of-the-art computational and storage infrastructure. In
addition to an extensive collection of trusted open-source tools, the Shared Resource will also provide access
to several licensed bioinformatic software tools such as Ingenuity Pathway Analysis, CLC Genomics
Workbench, Partek Flow, Schrodinger Molecular Drug Discovery suite, and BioCyc Database Collection.
Similarly, the computational infrastructure includes dedicated servers for data storage, high-performance
computing, database and web development and optional cloud computing. The Shared Resource offers a wide
range of bioinformatics services that fall into five thematic areas including (i) analysis of next-generation
sequencing (NGS)-based genomics data; (ii) analysis of array-based and systems biology data; (iii) machine-
learning, big-data analysis and precision medicine research; (iv) development of software and database
applications for bioinformatics projects; and (v) support for experimental design and grant consultation. In the
past funding cycle, the Shared Resource has supported several hundred distinct research projects with over a
third of the Shared Resource users hailing from the Fred and Pamela Buffett Cancer Center (BCC). The
Shared Resource Director is assisted by four well-trained support staff with diverse training backgrounds in
computer programming, statistics, cancer genomics, and systems biology. An advisory board that consists of
members representing different colleges at UNMC oversees the Shared Resource policies and procedures and
makes recommendations. The Shared Resource Director also leads a research program in cancer genomics
and bioinformatics, mentors students in the Cancer Biology Training Program and collaborates with a number
of BCC investigators to facilitate the development of customized data analysis protocols that meet the evolving
needs of cancer researchers.